Inside out: Revealing strategies for intracellular S. aureus persister eradication

Project Summary
Antibiotic treatment failure imposes a significant global health and economic burden. Even in the absence
of resistance mutations, the recurrence of infections can be attributed to a resilient subset of genetically identical
bacteria. This phenomenon, recognized as antibiotic-tolerant persister formation, also facilitates the development
of resistance, underscoring a critical challenge that demands attention. Mounting evidence suggests that the
intracellular environment plays a pivotal role in the formation of persister cells, serving as a crucial reservoir for
these bacterial populations. Among the most difficult-to-treat bacterial pathogens, Staphylococcus aureus can
survive antibiotic exposure within host cells, including macrophages, and subsequently resume growth when
conditions become favorable again. However, the intracellular niche of S. aureus in vivo and the underlying
mechanisms driving persister formation remain largely enigmatic. This knowledge gap can be attributed to the
challenge of distinguishing viable persisters from non-viable bacteria and the low frequency of cells harboring
live bacteria (less than 0.01% of overall cells extracted from mouse organs). To address this hurdle, I have
developed inducible reporter strains that will enable the identification of intracellular reservoirs in vivo. Using
single-cell approaches, I will identify the host cells containing S. aureus and the antibiotic-tolerant persisters (Aim
1.1). Both the host and intracellular bacterial transcriptomes will be probed using single-cell RNA-sequencing
(scRNA-seq) and a novel single-cell bacterial RNA-seq technology called proBac-seq (Aim 1.2 & 1.3). I have
also established a high-throughput screening platform aimed at identifying energy modulators of intracellular S.
aureus, as the low energy state is the central characteristic underlying persister cells’ insensitivity to antibiotics.
My preliminary screen of >4,700 drug-like compounds has identified a compound (KL1) that increased the
energy level of intracellular S. aureus as well as its susceptibility to antibiotics. Further understanding of its
mechanism of action using the chemoproteomic method thermal proteome profiling (TPP) will unravel novel
therapeutic target(s) for devising antibiotic adjuvants (Aim 2.1). Lastly, I intend to explore potential host-directed
energy modulators from a select library of established mammalian kinase inhibitors targeting intracellular
immune responses (Aim 2.2). These studies will provide a comprehensive understanding of the interplay
between host responses and antibiotic tolerance within the intracellular milieu.

Public health relevance
Project Narrative Antibiotic tolerance enables a subpopulation of genetically identical bacteria to withstand multiple antibiotics over an extended duration, causing treatment failures and relapsing infections. The ability of Staphylococcus aureus– one of the leading bacterial causes of death–to hide inside host mammalian cells and form tolerant persisters largely reduces the therapeutic efficacy of antibiotics. I will use a combination of transcriptomic, pharmaceutical and single-cell approaches to dissect the survival mechanisms of intracellular S. aureus persisters, aiming to develop innovative strategies to control and eradicate this difficult-to-treat intracellular bacterial population.